Adolescent Wellness Visits in Tanzania

Abstract
Adolescents are less likely to access prevention-oriented health services such as HIV
testing and counseling (HTC) and contraception than adults, yet young people bear a
disproportion burden of poor HIV and reproductive health outcomes in many low-
resource settings. This study evaluates a new service delivery platform for reaching
adolescents in Tanzania with HTC and other evidence-based screening services via
clinic-based ‘Adolescent Wellness Visits’ coordinated between primary schools and
health facilities that offer a package of youth-friendly services. We posit that by coupling
sexual and reproductive health (SRH) services with non-SRH services such as nutrition,
vision, dental and mental health screenings, applicable for all adolescents, adolescent
health service use including HTC will increase and a tone will be set for a ‘culture of
health and wellness’ during this critical developmental period.

Public health relevance
PROJECT NARRATIVE Adolescent Wellness Visits in Tanzania: Bundling evidence-based prevention services to increase uptake of HIV Testing and Counseling and other health services Adolescents are less likely to access prevention-oriented health services such as HIV testing and counseling (HTC) and contraception than adults, yet young people bear a disproportion burden of poor HIV and reproductive health outcomes in many low-resource settings. This study evaluates a new service delivery platform for reaching adolescents in Tanzania with HTC and other evidence-based screening services via clinic-based ‘Adolescent Wellness Visits’ coordinated between primary schools and health facilities that offer a package of youth-friendly services. We posit that by coupling sexual and reproductive health (SRH) services with non- SRH services such as nutrition, vision, dental and mental health screenings, applicable for all adolescents, adolescent health service use including HTC will increase and a tone will be set for a ‘culture of health and wellness’ during this critical developmental period.